Fentanyl induces naloxone-resistant vocal cord closure: target validation and development of opioid overdose treatments using a peer-reviewed animal model.

PROJECT SUMMARY:
According to the Centers for Disease Control (CDC), synthetic opioids are currently the most common
cause of
overdose death in the U.S., and have increased opioid deaths by >500% from 2015- 2020. In 2020 alone,
over 80% of the 69,700 opioid deaths were attributed to these synthetics (fentanyl). Despite the
widespread availability of naloxone, the only FDA approved treatment for opioid overdose, deaths from
fentanyl and fentanyl analogues (F/FA) continue to rise in parallel with increasing reports and
pharmacological evidence of F/FA resistance to naloxone. High doses of rapidly injected F/FA cause
airway obstruction from vocal cord closure (VCC) and severe chest wall rigidity (CWR) within 60-90
seconds, lethal effects that can persist for up to 10 minutes and appear to be resistant to naloxone. In
contrast, morphine derived opiates (e.g. heroin) cause respiratory depression and mild muscle rigidity that
is responsive to naloxone, but are not known to cause VCC in humans. The rapidly lethal phenomenon of
VCC suggests unique pharmacological mechanisms underlying F/FA effects and may be a factor driving
the dramatic increase in community overdose deaths. In support of this hypothesis, our published
pharmacological data demonstrate F/FA, but not morphine or naloxone, have affinity for off-site targets
that regulate these F/FA-induced effects. These in vitro data include F/FA concentrations that may be
physiologically relevant to humans, based on available models of brain lipid concentrations for F/FA and
by comparison with plasma levels in decedents of fentanyl overdose. Additionally, we have demonstrated
in our published animal model that intravenous fentanyl induces VCC in <10 seconds, is not reversed by
high dose naloxone and involves these off-site receptor targets. These data suggest that the development
of effective therapies for overdose requires a biological model that replicates clinical effects of F/FA
toxicity and a re-conceptualization of the underlying causes of F/FA overdose deaths to include VCC, in
addition to respiratory depression. Therefore, the goal of this Fast-track proposal is to use an animal
model of fentanyl toxicity, to identify specific drug classes that address F/FA induced VCC and
respiratory depression. There are currently no Federal Drug Administration approved treatments that
target these F/FA toxicity effects, and this project directly addresses the need for the development of a
new class of therapeutics, specific to F/FA overdose.

Public health relevance
PROJECT NARRATIVE: Data from the Centers for Disease Control (CDC) indicate that fentanyl and fentanyl analogues (F/FA) are the most common cause of overdose death in the U.S., underscoring the critical need for more effective overdose treatments in the ongoing opioid crisis. Torralva Medical Therapeutics, LLC has developed an animal model that replicates the unique effects of fentanyl toxicity seen in humans (vocal cord closure) and has begun target validation and development of novel formulations to effectively antagonize fentanyl doses that are routinely fatal. These formulations will solve the unmet critical need to treat naloxone-resistant effects of F/FA overdose, have the advantage they can be used for morphine- derived drug overdose (e.g. heroin) or combinations of F/FA with morphine-derived drugs, and have the potential to dominate the U.S. market for opioid overdose treatment currently estimated to be over $300 million.